Targeted Circuit Manipulation for Ameliorating Huntington's Disease Pathogenesis

PROJECT SUMMARY/ABSTRACT
This exploratory project is a collaboration between Huntington's disease (HD) researchers and BRAIN tool
developers and will utilize novel interventional tools for changing neural circuit dynamics to causally link brain
activity to behavior in the context of HD. Almost 30 years after identifying the genetic mutation causing this
debilitating neurodegenerative disease, treatments remain limited to managing late-stage symptoms of motoric,
psychiatric, and cognitive deficits. Findings from patients and mouse models of HD point to pre-symptomatic
imbalances in neuronal circuit activity, well before any overt symptoms are observed. This project will explore
modulating specific microcircuits in the HD brain using tools developed under the BRAIN initiative. Our central
hypothesis is that manipulating the firing activity within selected microcircuits before the onset of symptoms by
chemogenetic inhibition and/or excitation of key target populations will slow HD disease progression. A crucial
early event in HD is the pathological increase in the overall excitatory output from cortex onto striatum. Underlying
mechanisms could be enhanced excitability of cortical pyramidal neurons (PNs) and/or decreased inhibition by
cortical parvalbumin interneurons (PVs) that provide the main inhibitory drive onto PNs. Stimulating PVs offers
a physiologically relevant approach, as it restores this critical input while preserving other modulating synaptic
inputs to the PNs (Aim 1). A second, and more direct, correction is to decrease the firing of the PNs themselves
(Aim 2). Finally, a third approach will convert excitatory synapses into inhibitory ones at the PN terminals which
would directly reduce the hyperactivity of specific striatal neurons during the prodromal phase of the disease
process (Aim 3). Our major goal will be to determine which of the three key entry points provides the most
efficacious strategy for preventing or delaying and mitigating the behavioral deficits in the R6/2 transgenic mouse
model of HD. For manipulation of neuronal activity this project will utilize the bioluminescent optogenetic (BL-
OG) platform that employs light emitting luciferases to activate light sensing opsins, including the recently
developed ‘interluminescence’ approach that enables controlling synaptic transmission by expressing the light
emitter and sensor in pre- and post-synaptic partners, respectively. To achieve our goals, we are combining
expertise in circuit manipulation tool development and HD mouse model behavioral research towards a more
refined understanding of the brain mechanisms underlying complex behaviors. At the same time our project will
drive translational progress toward potential novel therapeutic purposes. In addition to the impact on HD research
our results are expected to have a significant impact on approaching other neurodegenerative diseases that
show circuit imbalances.

Public health relevance
PROJECT NARRATIVE The BRAIN initiative has enabled the development of approaches for modulating specific microcircuits through genetically targeting discrete types of neurons; however, their application to disease models is lagging. In this collaboration between Huntington’s disease (HD) researchers and BRAIN tool developers we will utilize novel interventional tools for changing neural circuit dynamics at the early, pre-symptomatic stage for preventing or delaying and mitigating the behavioral deficits in a transgenic mouse model of HD. Our project will drive translational progress toward potential novel therapeutic purposes for HD as well as other neurodegenerative diseases that show circuit imbalances, while at the same time addressing basic questions of neural circuit function underlying behavior relevant to both NINDS and NIMH.